DP21-001 Pregnancy Risk Assessment Monitoring Systems (PRAMS), Component A: Core Surveillance

Oregon PRAMS Project Summary/Abstract
Oregon’s Pregnancy Risk Assessment Monitoring System (PRAMS) conducts surveillance on selected
maternal behaviors and experiences that occur prior to, during and shortly after pregnancy. Because of
the design of the survey, weighting which includes an emphasis on gathering data equitably from six
racial and ethnic subpopulations, and a high response rate, the PRAMS surveillance data are very high
quality and offer far more breadth and depth than birth certificate data. The Oregon Maternal and Child
Health Section has also leveraged PRAMS into a longitudinal data collection system by re-interviewing
respondents when the index child is 3 years old via the Early Childhood Health in Oregon survey. The
PRAMS+ECHO surveillance system provides data for Oregon's Needs Assessments (including Title V and
Home Visiting), for monitoring the health status of Oregon women and children, for informing state and
local public health department program and policy efforts, and for research into emerging health
problems and public health practice. The data have recently been used to monitor maternal mental
health during and after pregnancy, safe to sleep/back to sleep habits, breastfeeding, maternal
substance use during pregnancy (alcohol, commercial tobacco, e-cigarette, marijuana, and prescription
painkillers), maternal leave employment practices, and periconceptional folic acid.

Public health relevance
Oregon PRAMS Project Narrative The Pregnancy Risk Assessment Monitoring System (PRAMS) surveys mothers of 2-3 month old babies about their and their child’s health. By answering questions about health and behavior before, during, and after pregnancy, PRAMS participants help us learn more about challenges facing Oregon mothers and babies. We use this information to improve programs, create policy, and support families throughout the state.